Genomics/Endocrine/Statistics Core

The overall purpose of the Genomics/Endocrine/Statistics Core is to provide a common set of state-of-the-art biochemical and genetic analyses as well as statistical support to NCDDG researchers. The laboratories of the Core will provide assessments of hypothalamic-pituitary-adrenal axis and endocrine function, detailed genetic analyses and statistical support to the individual research projects of the NCDDG. Having these determinations performed by a central facility using a common set of assay modalities, common databases and statistical expertise will provide consistency across the 5 projects included in this 5 year study. Additionally, having a Core devoted to these analyses will guarantee high quality assay performance, allow for economies-of-scale in the purchase of assay reagents and technician time, and enable NCDDG investigators to more fully concentrate their efforts on the unique aspects of their particular project.

Public health relevance
Mood and anxiety disorders are the most common of all psychiatric disorders and are associated with very significant morbidity and mortality. The primary goal of NCDDG Center is to accelerate the development of novel drugs for the treatment of depression and anxiety. The Genomics/Endocrine/Statistics Core will provide a common set of state-of-the-art biochemical and genetic analyses as well as statistical support to NCDDG researchers.